Novel mechanisms of macrophage foam cell formation.

Project Summary
In the development of atherosclerotic plaques, macrophages infiltrate the intima of the aortic wall to
digest modified lipoproteins. Over time, these macrophages become lipid laden foam cells. Most modified
lipoproteins are aggregated and crosslinked to the extracellular matrix of the vessel wall, which prevents them
from being phagocytosed by macrophages. We have described how macrophages digest aggregated LDL
extracellularly using a process termed digestive exophagy. Macrophage first form a sealed, acidified
extracellular compartment around aggregated LDL. Lysosomes are then secreted into this compartment,
allowing lysosomal acid lipase to hydrolyze cholesteryl esters into free cholesterol. However, it remains unclear
how this excess extracellular free cholesterol is transported into macrophages for lipid droplet formation.
Moreover, recent cell-lineage analyses showed that most foam cells found in plaques are of smooth muscle
cell origin and not macrophages. This discovery is intriguing because smooth muscle cells are not capable of
digestive exophagy. My proposed research aims to elucidate the molecular mechanisms that can help address
these two existing research questions, which would provide alternative mechanisms for foam cell formation.
Based on my preliminary results, I hypothesize that the cholesterol transport protein, STARD4, can mediate
the transport of free cholesterol from the plasma membrane of macrophages to the ER for lipid droplet
biogenesis (Aim 1). In Aim 1.1, I propose to investigate changes in HDL metabolisms in STARD4 knockout
macrophages with lipid mass spectrometry. In Aim 1.2, I will examine if the in vitro finding would translate to a
delay in plaque formation in mouse models. Furthermore, I hypothesize that the lysosomal cholesterol
transport proteins NPC1 and NPC2 can help transporting and inserting free cholesterol from the extracellular
compartment to the plasma membrane of macrophages (Aim 2). Finally, I hypothesize that smooth muscle
cells turn into foam cells by absorbing free cholesterol released by neighboring macrophages during digestive
exophagy (Aim 3).
My proposed studies will expand our understanding of the basic biology of Mϕ-agLDL interactions – a
poorly understood and often overlooked process that underlies the development of atherosclerotic plaques. My
pilot studies on STARD4 demonstrated that loss of STARD4 specifically impaired aggregated LDL-mediated
foam cell formation and not acetylated LDL-mediated foam cell formation. Thus, the characterization of how
extracellular free cholesterol released from digestive exophagy enters Mϕs and contributes to foam cell
formation would open an avenue for novel therapeutic approaches. Designing or identifying inhibitors that slow
down the incorporation of PM free cholesterol into lipid droplets could slow down foam cell formation in a
manner that is independent of current treatments, and this may provide additive effect when used in
combination with current treatments.

Public health relevance
Atherosclerosis, defined by the narrowing and hardening of the arteries due to the buildup of fatty plaques, is a leading cause of cardiovascular disease in the United States. Plaque development begins with the formation of macrophage foam cells, but treatments targeting this process based on current knowledge have not been fruitful. My proposed studies aim to understand an alternative mechanism for macrophage foam cell formation, with the hope of identifying novel targets for future therapeutic development.